Client Language Analysis in Veterans and Non-Veterans with Low Motivation to Quit Smoking: Identifying Mechanisms of Change

Background: Veterans disproportionately suffer cigarette-related disease and death relative to the general
population, but Veterans often endorse low motivation to quit. Analysis of client language with unmotivated
smokers may provide new insights into how motivation shifts in response to different therapies. Therapies for
unmotivated smokers include motivational interviewing (MI), which aims to enhance intrinsic motivation by
resolving ambivalence; and health education (HE), which delivers scripted health advice. MI research suggests
that increased in-session client “change talk” (CT), or language reflecting commitment to change the target
behavior, relative to “sustain talk” (ST), or language reflecting plans to continue the target behavior, is
associated with improved treatment outcomes. HE may contain client statements reflecting learning, or
“learning talk” (LT), in response to health information, which may lead to improved outcomes through a
different therapeutic mechanism. We propose to analyze client language from two randomized controlled trials
(RCTs) comparing MI to HE with unmotivated smokers conducted by our Co-Investigators, including 1) a
community RCT with 255 unmotivated smokers; and 2) a Veterans Health Administration (VHA) pilot study with
85 Veteran smokers with mental illness, of which a subset reported low motivation to quit. Analysis of client
language in MI and HE sessions from these studies with unmotivated smokers will provide insight into the
mechanisms underlying MI and HE. Significance/Impact: Given the high prevalence of smoking in Veterans,
identifying therapeutic techniques associated with positive outcomes in unmotivated smokers has great
potential to improve Veteran health. This project addresses HSR&D priorities of mental health, primary care
practice, and quality/safety. Innovation: This mixed methods project is the first of its kind to examine aspects
of in-session client language as predictors of treatment outcomes in unmotivated smokers, a population
representative of most Veteran smokers in VHA care. Specific Aims: Aim 1 is to code client language in audio
recorded MI and HE sessions from two RCTs with unmotivated smokers, including a community sample and a
Veteran sample. We hypothesize that in both datasets, proportion of CT will be higher in MI than HE and that
LT will be higher in HE than in MI. Aim 2 is to examine the relationship between proportion of CT to ST and
proportion of LT to RT and 3- and 6- month treatment outcomes in the community sample. We hypothesize
that that a higher proportion of CT relative to ST will be positively associated with treatment outcomes, both in
MI and HE; that a higher proportion of LT relative to RT will be positively associated with outcomes, both in MI
and HE; and that both high CT and high LT in the same session will be associated with improved outcomes
relative to either high CT alone or ST alone irrespective of treatment group. We also hypothesize that
proportion of CT will mediate treatment effects in MI, and proportion of LT will mediate treatment effects in HE.
Aim 3 is to use results to develop a brief manual for Veteran smokers incorporating HE and MI. Methodology:
We will use mixed methods to code and analyze 102 MI and 102 HE sessions from the community RCT and
15 MI and 15 HE sessions from the VHA RCT. To code sessions, we will use the Motivational Interviewing Skill
Code 2.5 (MISC 2.5), a validated MI client language measure, to code CT and ST; and a LT coding extension
system of the MISC 2.5 developed by our team to quantify client language LT, or reflective of client learning;
and client rejection of health information, or rejection talk (RT). We will use findings to develop a brief manual
for unmotivated Veteran smokers in VHA clinics. Throughout the project, we will work with an advisory panel of
Veteran stakeholders and VHA leaders, who will provide input on the manual. Implementation/Next Steps:
The ultimate goal of the project is to identify therapeutic mechanisms of action underlying MI and HE for
unmotivated smokers. Findings will allow our team to apply for funding to test a brief intervention incorporating
effective techniques from both HE and MI for unmotivated veteran smokers in VHA clinical settings.

Public health relevance
Veterans smoke cigarettes at higher rates than the general population, yet most Veterans in VHA care report low motivation to quit. Motivational interviewing (MI) is most commonly used for unmotivated smokers, but data suggests health education (HE) may also help unmotivated smokers. Client language can provide insights into therapeutic techniques associated with behavior change. To elucidate this issue, mixed methods will be used to code and analyze 102 MI and 102 HE sessions from a large community RCT to examine the relationship between key aspects of client language, including statements reflecting plans to change (“change talk”) and evidence of client learning (“learning talk”), and 3- and 6-month treatment outcomes. We will also code and analyze 15 MI and 15 HE sessions from a VHA RCT that included a sample of unmotivated Veteran smokers with mental illness to assess for proportion of CT, LT, and other aspects of client language. Results will be used to combine MI and HE techniques to develop a brief intervention for unmotivated Veteran smokers.